MicroRNA as a target for fetal hemoglobin inducing agents in sickle cell disease

My long-term research goal is to develop effective pharmacological interventions that can alleviate disease
progression and improve the quality of life for patients with sickle cell disease (SCD). Approximately 100,000
Americans–primarily African or Hispanic background–suffer from SCD, featured with recurrent episodes of
acute vaso-occlusion, hemolytic anemia, and progressive organ damage. The only FDA-approved drug for
SCD, hydroxyurea, induces fetal hemoglobin (HbF) production, decreases disease severity, and benefits
overall mortality. However, the ability of hydroxyurea to induce HbF is highly variable, with over 50% of patients
do not respond to hydroxyurea. There remains a critical and urgent need to identify additional HbF-inducing
therapeutic agents.
Among a large number of epigenetic mechanisms that have been explored for -globin gene reactivation,
lysine specific demethylase1 (LSD1) has emerged as an attractive target. Research from our group showed
that RN-1, a selective inhibitor of LSD1 significantly stimulated -globin gene transcription and reduced disease
pathology in a mouse model of SCD. Ongoing study in baboons has confirmed enhanced HbF production by
RN-1. However, the mechanism by which LSD1 inhibitor induces HbF is not known. Moreover, recent studies
on microRNA (miRNA) have shed lights on the identification of novel HbF inducing agents. Suppression of let-
7a miRNA significantly increased HbF expression in adult human erythroblasts. My own work has identified let-
7 as an epigenetic mechanism in the neuropathogenesis of SCD. Uniquely, my preliminary data suggest that
RN-1 improves SCD by mechanisms that involve circulating exosomal miRNA. Therefore, it is scientific
compelling to elucidate the intriguing interactions between LSD1 and let-7 miRNA in SCD.
While much of the research has been focused on ameliorating clinical severity of SCD, pain can represent
as another major therapeutic outcome. SCD is not only characterized by acute exacerbations of pain (acute
pain), but also intractable persistent pain throughout a patient's life. Chronic pain is refractory to current
medications and represents a significant unmet medical challenge. Increased levels of HbF can alleviate
disease symptoms and decrease acute painful episodes. However, scientific evidence for an effect of
hydroxyurea on chronic pain in SCD is lacking. In this application, I propose to employ pain as an innovative
approach to measure the outcome of inducing HbF. I will test the hypothesis that let-7 miRNA is a novel target
of LSD1 to modulate HbF silencing and chronic pain in SCD.
By identifying molecular and epigenetic mechanisms of LSD1 and let-7 miRNA in SCD, specific targeting of
these mechanisms holds great promise of designing effective therapies that can benefit patients with SCD.
Successful completion of the study will not only achieve my training objective to transit to an independent
academic investigator, but also build up a strong scientific framework for future research and R01 applications

Public health relevance
Sickle cell disease (SCD) affect 100,000 Americans, people mainly of African or Latin descent. There is a severely unmet medical need for the treatment of SCD and SC pain that is not only a life-long companion but also a predictor of mortality rate. Working with my mentors and other senior colleagues at the UIC Sickle Cell Center, I have designed a comprehensive research proposal to address these problems, as well as a career development plan to establish an independent and vibrant research program that will allow me transit into an independent academic career.